Mechanisms underlying CD3 guided assembly of retinal circuits

The mammalian nervous system is composed of billions of neurons, and the precise assembly of these
neurons into circuits ensures proper functionality. In the retina, the diverse but precise wiring between bipolar
cells (BCs) and retinal ganglion cells (RGCs) serve as the structural basis for circuit processing of visual signals
from outer retina to the inner retina. Defects in these wirings lead to severe retinal diseases. The most common
example of these diseases is glaucoma, which imputes a significant social and economic burden on the US
population. A major obstacle to developing effective therapies to regenerate BC to RGC wirings is our poor
understanding of the structure of these circuits and the mechanisms ensuring BCs and RGCs to wire up
precisely. In this proposal, we illustrate the cellular strategy of function specific BC to RGC wiring and how CD3ζ
selectively instruct RGCs to target various BC types for wiring. To illustrate the assembly of function-specific
circuits, we developed a novel transcellular labeling technique to label BCs synaptically wired to function-specific
RGCs. Our results on a specific type of DS-RGCs, BD-RGCs, are comparable to those from EM connectomic
studies. Our results also show that two different RGC types synapse with distinct BC types, suggesting RGC
type-specific wiring with BC types. These studies position us to examine more RGC types and to reveal the
underlying mechanisms guiding the assemble of each RGC type with various BC types. Toward this end, we
found that mutation of CD3ζ, a receptor for class I major histocompatibility complex (MHCI), eliminates synaptic
connections of cone BCs to BD-RGCs but increase synaptic connections of cone BCs to J-RGCs, thus allowing
RGC type-specific synaptic regulation. The defects in synaptic wiring of cone BCs to BD-RGCs in CD3ζ mutants
significantly impair the light-evoked responses of BD-RGCs, suggesting that precise BC-RGC synaptic wirings
are necessary to ensure function specificity of RGCs. To further test this idea, we will identify the BC types wired
to additional 4 RGC types and the synaptic function of these RGCs to reveal the cellular strategy responsible for
specifying RGC function. We will also examine how CD3ζ instructs synapse formation and function of these
RGCs. To uncover the mechanisms underlying CD3ζ-mediated synaptic assembly, we showed that knockdown
or overexpress CD3ζ in RGCs of wildtype mice or CD3ζ mutants only induced phenotypes in transduced RGCs,
suggesting a cell-autonomous mechanism. To further expand our understanding of the mechanisms, we will
perform a series analyses to determine whether CD3ζ is specifically required for the dendritic development of
RGCs, whether it is sufficient for the dendritic development of RGCs, and whether it is required to maintain
dendritic stability in adults. Thus, we will examine the roles of CD3ζ in the BCs to RGCs wiring using our newly
generated molecular and genetic tools. Collectively, our studies seek to reveal the strategy and mechanisms
that control RGCs type-specific circuit formation. These studies will constitute a significant step forward in
understanding the mechanisms underlying the development of function-specific circuits.

Public health relevance
The mammalian nervous system is composed of billions of neurons that precisely assembled to form function-specific circuits for proper functionality, and defects in these circuits might lead to severe CNS diseases. For the visual system, a significant obstacle to developing effective therapies to regenerate retinal circuits and restore vision is our poor understanding of the structure of these circuits and the mechanisms ensuring retinal neurons to wire up precisely. In this study, we seek to reveal the cellular strategy and mechanisms that control RGCs type-specific circuit formation, and accomplishing this study will constitute a significant step forward in understanding the mechanisms underlying the development of function-specific circuits and thereby fostering the design of new treatments for visual impairment.